IGF::OT::IGF Administrative Cost - Contract Orientation & Kick Off Mtg, HHSN261201700013I, DTP-17-038, 08/01/17 - 09/30/17, Analysis of Anti-Cancer Chem & Pharm Formulations, PRB.

Teleconference meeting